Transgenic Animal Models (TAM)

PROJECT SUMMARY/ABSTRACT (TRANSGENIC ANIMAL MODELS SHARED RESOURCE)
The Transgenic Animal Models Shared Resource (TAM-SR) was formally established in 1989 to provide
specialized equipment and expertise in transgenic technology and genome engineering to University of Michigan
(U-M) faculty. Recognizing its high scientific impact, TAM-SR had been continuously funded by the Cancer
Center Support Grant (CCSG) since 1996. The CCSG in combination with institutional support provides Rogel
Cancer Center (Rogel) members with a cost-effective resource that eliminates the need to independently
establish resource intensive assets in their individual laboratories. TAM-SR provides specialized equipment and
staff trained in embryo micromanipulation, CRISPR/Cas9 reagent construction/validation, embryonic stem cell
culture, and provides training in these technologies. Rogel members benefit from the ability to use genetically
engineered mouse models in their research at a reasonable cost because of the SR’s extensive capabilities and
expertise as well as institutional and CCSG support. TAM-SR is located in the School of Medicine in close
proximity to the majority of Rogel members.